Synthesis at the Interface of Chemistry and Biology

Project Summary/Abstract
This proposal explores three major aspects of synthetic biology- all under the related theme of
the evolution of life: a look forward into evolution by creating organisms with an expanded
genetic code, and a look back into evolution by exploring the evolution of mitochondria in a well-
defined “synthetic” endosymbiont system, and by exploring one possible mechanism for the
transition from the RNA to DNA world through the generation and characterization of bacteria
with chimeric DNA-RNA genomes. Specifically, we will genetically encode D-amino acids in
bacteria and create and apply a genetically encoded tool to study protein folding/unfolding on a
sub-microsecond timescale; we will begin to minimize our bacterial endosymbiont genome by
deleting metabolic and cell wall biosynthetic genes, as well as exploring those factors that
contribute to the stability of this chimeric system; and create a biorthogonal replication system
and use it to explore those factors that allow the incorporation of large numbers of
ribonucleotides into bacterial DNA.

Public health relevance
Project Narrative This proposal explores three major aspects of synthetic biology- all related to the evolution of life: a look forward into evolution by creating organisms with an expanded genetic code, and a look back into evolution by exploring the evolution of mitochondria in a well-defined “synthetic” system, and by exploring one possible mechanism for the transition from the RNA to DNA world through the generation of bacteria with chimeric DNA-RNA genomes.